Customizable cooperative multi-joint control to enhance walking mobility after stroke

Most stroke survivors walk slowly and are at an increased risk of falls. As a result, many adopt a
sedentary lifestyle with limited functional independence that negatively impacts health and can be socially
isolating. Physical therapy including advanced rehabilitation techniques have improved function, but there is no
intervention available that enables stroke survivors with moderate and severe impairment to walk at speeds
necessary for independent community ambulation. The long-term goal of this work is to restore stroke
survivors’ ability to walk safely in the community at speeds necessary for independence. Our approach utilizes
an implanted neuroprosthesis, that is a device inside the body that applies small electrical pulses to activate
the nerves that cause the muscles serving multiple joints to contract in a coordinated manner for functional
movement of the entire limb. The system measures volitional muscle activity and body motion and then
coordinates stimulation at the different joints in the leg to produce the necessary movement for safe walking at
functionally relevant speeds. The benefit of such an approach is that it is always available and does not require
setup for individuals with impaired hand control. The implanted hardware also improves reliability and
bypasses sensory fibers that can cause discomfort. Our team has shown in a case study that targeting
muscles throughout the paretic limb can substantially improve walking speed and endurance. This study will
expand this work through achieving the following Aims: 1) determining the clinical impact of an implanted multi-
joint neuroprosthesis on post-stroke gait, and 2) developing and assessing an advanced neuroprosthesis
cooperative control strategy. This study will implement an available neuroprosthesis that incorporates an
external control unit and some external sensors in preparation for implementation of a fully implanted system
that has been developed at our Center. Six participants will be implanted with devices that include 12-channels
of stimulation and 2-channels for recording muscle activity. External sensors will measure limb motion. After
the device is implanted, stimulation patterns will be generated and participants will undergo training to use the
device. A simple triggering pattern will be created for home use and then we will implement our advanced
controller in the laboratory via machine-learning techniques. Once a controller and stimulation pattern have
been defined, we will determine how much faster, more safely, and easier walking is with the neuroprosthesis
compared to without and confirm whether these effects are maintained over time. We will also determine if the
advanced controller substantially improves walking ability over the simple triggering methods that have been
previously implemented. Successful completion will confirm approaches for a post-stroke neuroprosthesis for
walking and generate preliminary effect sizes for subsequent clinical trials to evaluate home and community
use of a fully implanted system. This study may lead to a new clinical tool that can empower independent
walking after stroke, improve quality of life, and enhance overall health of stroke survivors.

Public health relevance
Millions of stroke survivors have difficulty walking due to weakness on one side of the body; many individuals adopt sedentary lifestyles, worsening their health and quality of life. In the short-term this study will determine preliminary efficacy of a device for significantly improving mobility and independence after stroke while defining techniques for implementation. Long-term, this should result in a clinical intervention that substantially improves walking speed, reduces fall risk, increases activity levels and overall health, and facilitates community access and independence.